Long-term safety and effectiveness of Dengvaxia in the Philippines

Abstract
The four serotypes of dengue virus (DENV1–4) are the leading cause of mosquito-borne viral diseases in
humans. Dengvaxia, the first licensed dengue vaccine, was recommended for individuals aged 9–45 years in
2016. In the Philippines, a school-based vaccination program was launched in April 2016 with >830,000
children receiving Dengvaxia without prior serological testing. Subsequently, DENV-seronegative children who
received Dengvaxia developed severe disease after breakthrough DENV infection (BTDI). This resulted in the
revised recommendation in 2018 that Dengvaxia be administered only to DENV-seropositive individuals. Thus,
thousands of Filipino children are at higher risk of severe dengue disease. Studies have shown the efficacy of
Dengvaxia waned over time especially among baseline DENV-seronegative recipients, underscoring a critical
need for elucidation of antibody and T-cell responses induced by Dengvaxia. Our understanding of Dengvaxia
was primarily based on efficacy trials with 3-dose regimen. A knowledge gap exists regarding the risk of severe
disease and effectiveness in the real world, where most individuals received only 1 or 2 doses and presented
with BTDI. In collaboration with the Research Institute for Tropical Medicine, our recent study demonstrated the
feasibility of our DENV1–4 nonstructural protein 1 (NS1) IgG ELISA to determine the baseline DENV
serostatus of Dengvaxia recipients during both BTDI and other febrile illness (OFI) in the Philippines.
Our long-term goal is to facilitate the development of next-generation dengue vaccines and to reduce the global
disease burden of dengue. The objective is to understand the long-term effects of Dengvaxia, a chimeric yellow
fever tetravalent dengue vaccine, and the immune responses induced in the Filipino population. The central
hypothesis is that Dengvaxia induces antibody and T-cell responses inferior to natural infection, leading to
limited type-specific neutralizing antibodies, weak T-cell responses and waning vaccine efficacy especially for
baseline DENV-naïve recipients. The first aim is to determine the baseline DENV serostatus of Dengvaxia
recipients in the Philippines and assess the long-term safety and effectiveness of Dengvaxia. The second aim is
to characterize antibody and T-cell responses induced by Dengvaxia prior to and after BTDI.
The proposed research is innovative as it combines RT-PCR and IgM ELISA used in routine dengue fever
surveillance and our recently validated DENV1−4 NS1 IgG ELISA to determine baseline DENV serostatus
under field conditions and provides new insights into the safety and effectiveness of Dengvaxia after mass
vaccination through a manufacturer-independent study as opposed to that derived from vaccine efficacy trials.
Given that previous immunogenicity studies of Dengvaxia primarily focused on neutralizing antibody titers, our
in-depth study of antibody responses both qualitatively and quantitatively and T-cell responses to structural
and nonstructural proteins is highly significant. This information is translational and will facilitate the
development of next-generation live-attenuated tetravalent dengue vaccine or other chimeric vaccines.

Public health relevance
Narrative In 2016, Dengvaxia, the first licensed dengue virus (DENV) vaccine, was administered to >830,000 school- aged Filipino children without prior serological testing. Subsequently, DENV-seronegative children who received Dengvaxia developed severe disease after breakthrough DENV infection (BTDI) and the efficacy of Dengvaxia waned over time, underscoring a critical need for an in-depth understanding of antibody and T-cell responses following Dengvaxia vaccination. In collaboration with the Research Institute for Tropical Medicine Philippines, we will determine the baseline DENV serostatus of Dengvaxia recipients to assess the long-term safety and effectiveness of Dengvaxia, and characterize humoral and T-cell responses induced by Dengvaxia prior to and after BTDI.